The Black American United Memory & Aging Project (BA-UMAP): An examination of cognitive decline in midlife and older Black adults using remote cognitive assessments, risk factors & biomarkers

More research on the multi-level factors impacting the higher prevalence of Alzheimer’s disease and related dementias among Black adults is critically needed. The overall goal of this project is to increase our understanding of the biopsychosocial factors that impact cognitive outcomes in a cohort of 600 longitudinally followed middle-aged and older Black adults (aged 55+). This cohort, referred to as the Black American United Memory and Aging Project (BA-UMAP), will be established and maintained remotely using an innovative online, faceless enrollment and data collection strategy, and will involve: (a) a comprehensive assessment of biopsychosocial factors through online questionnaires; (b) annual cognitive assessments, administered remotely via computer and mobile devices; (c) the remote collection of non-invasive saliva and urine samples at baseline and Year 4; and (d) the utilization and integration of digital media platforms for creating a virtual community that provides outreach and education, and fosters trust. The overall objectives of this study are to: (1) prospectively evaluate cognitive functioning and identify preferences for remote cognitive assessment modalities; (2) identify sociocultural, behavioral, and environmental factors associated with cross-sectional cognitive functioning and longitudinal cognitive decline, and (3) examine the association of acquired biological risk factors, inclusive of family and health history, and salivary and urine biomarkers, to cognitive functioning and cognitive decline. This research is a necessary step in understanding the etiology of cognitive decline and, for informing future strategies for early detection and support for the development of remote methodologies for longitudinal brain health research among middle aged to older Black adults.

Public health relevance
Project Narrative The overarching goal of this research is to improve our understanding of the biopsychosocial factors that impact cognitive outcomes among middle-aged and older Black adults. This study, known as the Black American United Memory and Aging Project (BA-UMAP), will establish and remotely assess a cohort of 600 middle-aged and older Black adults in order to identify the sociocultural, behavioral, environmental, and biological factors influencing cognitive functioning and cognitive decline, as measured by established and novel online and mobile cognitive assessments, and remotely collected non-invasive biomarkers. It is hoped that this work will inform risk reduction strategies, given Black adults are disproportionately affected by Alzheimer’s disease and related dementias.